IMPLEMENT: Implementation outcomes and cost-effectiveness of developmental monitoring for children exposed to HIV

ABSTRACT
Children who are HIV-exposed, but uninfected (CHEU) are at higher risk for poorer neurodevelopmental (ND)
outcomes than children who are HIV-unexposed and uninfected (CHU), impacting their life trajectories and future
potential. With a growing population of CHEU, there is a critical need for implementation guidance to maximize
the impact of effective screening, diagnostic, and therapeutic interventions to address ND delay in high HIV
prevalence settings. Screening for ND delays typically involves a brief tool administered using either direct child
observation or based on caregiver-report. One such tool is the Global Scales of Early Development (GSED),
developed in partnership with the World Health Organization. Another promising approach for identifying children
at highest risk for ND delays is utilizing an automated risk score as a clinical decision support tool, which could
be embedded within an electronic medical record (EMR) system, pulling from existing clinical data closely linked
to ND outcomes and automatically calculating a score indicating risk of ND delay. However, it is unclear whether
implementing such a score is more pragmatic in real-world contexts than administering a ND screening tool. For
both options, a referral would be needed for further evaluation using a more detailed ND assessment, such as
the Malawi Developmental Assessment Tool (MDAT), and then intervention, if needed. Furthermore, it is unclear
whether targeted approaches focusing only on CHEU versus universal approaches for both CHEU and CHU,
are a better use of limited resources. Context-specific factors may impact how screening and referral services
can be feasibly integrated into maternal and child health (MCH) clinical programs. The cost-effectiveness and
affordability of screening, diagnostic, and therapeutic interventions are essential to inform country- or region-
specific policies, and modeling can be useful to simulate a broad range of potential implementation scenarios
and identify the most cost-effective approaches to ND intervention. Our objective is to evaluate the
implementation outcomes and cost-effectiveness of various developmental screening and intervention
approaches in diverse high HIV prevalence regions, which we will achieve in the following aims: 1) Validate and
pilot a predictive risk score tool and evaluate its implementation and usability compared to the GSED within
routine MCH clinic visits in Kenya, Botswana, and South Africa; 2) Identify determinants of implementation,
acceptability, feasibility, appropriateness, and cost of incorporating Project 2 (BONDS Study) ND evaluation and
interventions (Friendship Bench, optimal nutritional guidance, and parent-child play counseling) in Botswana,
Kenya, and Zimbabwe. and 3) Determine the cost-effectiveness of universal versus HIV-exposure status-based
screening, and the cost-effectiveness and budget impact of the Project 2 intervention bundle for ND within MCH
care in contexts with different HIV prevalence. This study will provide critical, concrete guidance to policymakers
to inform early, contextually specific policies for implementing ND screening, diagnostics, and therapeutics within
programmatic settings with high HIV prevalence.